Nikon Multiphoton (MP) Imaging System

PROJECT SUMMARY / ABSTRACT
Funds are requested to purchase a Nikon A1R Multiphoton (MP) Imaging System, to be integrated into the
Vanderbilt Cell Imaging Shared Resource (CISR). Vanderbilt has a history of excellence in biomedical imaging,
with outstanding facilities for human and live animal imaging within the Institute of Imaging Sciences,
groundbreaking molecular imaging within the Mass Spectrometry Research Center, and cutting-edge equipment
for advanced light microscopy within the CISR. However, the ability to integrate these outstanding resources to
image biologic processes across all scales – i.e. from the whole organism down to subcellular structure – has
been limited by the lack of an imaging solution to bridge live animal imaging to ex vivo imaging of tissues and
cells. The proposed MP System is capable of visualizing cellular events deep within the tissues of living
organisms through intravital imaging, providing a critical link between in vivo and ex vivo scales. A group of 12
NIH-funded User Groups across Vanderbilt will initially be supported by this instrument. These investigators have
unmet imaging needs to support NIH-funded projects spanning infectious diseases, immunology, neurobiology,
digestive diseases, epithelial biology, diabetes, lung injury, and cancer.
The proposed configuration of the MP System is based on the needs of the User Groups and includes: 1) a dual-
output laser with primary tunable beam (800-1300 nm) and secondary fixed (1040 nm) beam to support imaging
depth of up to 1.4mm, 2) a high-speed resonant scanner for dynamic imaging of up to 720fps, 3) a fully
automated, large-format stage and upright microscope stand to accommodate anesthesia and intravital
preparations, and 4) a selection of objectives specifically chosen to support the proposed User projects.
Additionally, with support from the Vanderbilt Institute for Infection, Immunology, and Inflammation (VI4), we
have already established a dedicated biosafety level 2 imaging suite with ancillary anesthesia, surgical, and
perfusion equipment to house the MP System and ensure that we can accommodate biohazardous specimens.
Vanderbilt is providing financial support to promote the long-term operation of the instrument, including salary
for technical staff and necessary service contracts. Technical support and training of new users will be facilitated
by the exceptional staff within the CISR, which has a greater than 20-year history of assisting over 300 labs on
campus. Moreover, the Nikon Center of Excellence housed within the CISR provides a dedicated local team of
specialists to support the microscopy needs of investigators on campus. Collectively, the proposed MP System,
together with outstanding institutional and core facility support, will enable the long-term objective of establishing
intravital imaging at Vanderbilt.

Public health relevance
PROJECT NARRATIVE This proposal will enable intravital microscopy at Vanderbilt through the procurement of a Nikon A1R Multiphoton (MP) Intravital Imaging System. The proposed equipment will fill a substantial unmet need in biomedical imaging to support multi-disciplinary research spanning infectious diseases, immunobiology, digestive diseases, cancer, epithelial biology, lung physiology, diabetes, and the neurobiology of addiction. When integrated among the outstanding core facilities and imaging resources on campus, the Nikon MP Imaging System will serve as a critical research node to meet the long-standing objective of visualizing biology across all imaging scales.